Intervention Impacts on Child Wellbeing and Parenting across Generations

Abstract
Maladaptive family environments marked by high chaos and violence, food insecurity, parent aggression and
lack of warmth, and parent mental health and substance use problems harm children’s development, costing
over $4.2 trillion in adverse child and family outcomes each year worldwide and lowering global GDP by 2-5%.
Maladaptive family environments are also passed across generations. One (mostly untested) hope of preventive
interventions in childhood is to disrupt cross-generational continuity in maladaptive family environments. We
hypothesize that intervention delivered to parents in one generation (G1) will lead to better parenting by their
children (G2) when they grow up to become parents, and intervention delivered to G2 children will lead to better
adjustment in their offspring (G3). This project tests intergenerational impacts of two different interventions in
which the original child participants have been followed into adulthood and are now parenting their own children.
First, the Great Smoky Mountains Study (GSMS) is a longitudinal study of three representative cohorts of children
(aged 9, 11, and 13) living in 11 counties in North Carolina (n=1420), with oversampling of American Indian
children (n=349), followed into their 30s. Three years after the start of the study, an income supplement was
given to every member of the Eastern Band of Cherokees following a casino opening, creating a natural
experiment. The GSMS has documented positive effects of this income shock on G1 parenting and G2 children’s
adjustment as participants grew into young adults. Second, the Fast Track (FT) randomized controlled trial
(n=891) tested the impact of a targeted intervention aimed at preventing violence in high-risk five-year-olds
through comprehensive training of G1 parents and social-cognitive skill-building delivered to G2 children.
Random assignment to FT had positive impact on G1 parents’ interactions with their children and G2 children’s
criminal behavior and mental health through age 25. Over the next five years, we will measure G2 parenting and
G3 behavior at the same ages that intervention effects had been documented in the prior generation. We will
test GSMS and FT intervention impacts on G2 parenting and G3 adjustment, examine intergenerational
continuity and discontinuity in parenting and child adjustment, and evaluate characteristics that might moderate
intervention impacts and intergenerational continuity in parenting and child adjustment. This research will have
high impact on public health by (1) estimating the extent to which two forms of childhood interventions (cash
transfers and intensive social-cognitive skill building) can affect family environments and child outcomes across
generations, (2) identifying risk and protective factors that disrupt intergenerational continuity in maladaptive
parenting and child adjustment problems as potential future intervention targets, and (3) evaluating lifespan
developmental processes to inform future practice and policy decisions regarding promising proximal targets to
reduce risk and improve children’s healthy development.

Public health relevance
Project Narrative This project tests intergenerational impacts of two different interventions (unearned cash transfers and social- cognitive skill building) in which the original child participants have been followed into adulthood and are now parenting their own children. This research will have high impact on public health by estimating the extent to which two forms of childhood interventions can affect family environments and child outcomes across generations. Risk and protective factors that disrupt intergenerational continuity in maladaptive parenting and child adjustment problems will be identified as potential future intervention targets, and lifespan developmental processes to inform future practice and policy decisions regarding promising proximal targets to reduce risk and improve children’s healthy development will be evaluated.